The roles of regional specialization, mechanical forces and epigenetic memory after perturbation and injury of the intestinal stem cell microenvironment

Project Summary The increased complexity of methods to analyze high-throughput genomic data, particularly single cell datasets, mandates the tight interaction between experimental and computational scientists. Analysis of how different compartments of the intestine interact with each other and react to insults is greatly advanced by studies at the single cell level. This project will accelerate progress of genomic analysis of the intestinal stem cell niche by ISCC members through the following two aims, (1) collaborations on projects from individual centers, and (2) collaboration on a consortium-wide project to determine the minimum set of genetic factors that support the intestinal stem cell niche using a comparative approach. In the previous year of this project, we have established collaborations with four ISCC teams to help with their project; we will now continue these collaborations and initiate two additional collaborations. For the consortium-wide project, we will generate new single-cell gene expression datasets to annotate a set of gene modules and communication modules in the intestinal stem cell niche in mouse and human. This project will deliver a set of conserved and derived factors that participate in the maintenance of the intestinal stem cell niche and a consortium-endorsed nomenclature of all mesenchymal, epithelial, and other cell subtypes in human and mouse intestine.

Public health relevance
PROJECT NARRATIVE The research proposed here will provide crucial insights into the core regulatory molecules that regulate the maintenance and function of stem cells in the human intestine. The work will promote a better understanding of: (1) the discrete cell types that make up the small intestine and colon, along with detailed molecular fingerprints for each; (2) which molecular components of intestinal stem cells are most conserved among mammals (and hence likely to be functionally relevant); (3) the signaling molecules that maintain intestinal stem cell function and their sites of production. This work will further yield a computational toolkit for annotating and interpreting future genomics studies of the mammalian intestine using a standard nomenclature for all cell states; this will bolster and unify past, present, and future studies of gastrointestinal cancer, infection, autoimmune conditions, and other human patient conditions under a common systematic framework.